CORE--INFORMATION AND DATA MANAGEMENT

The overall goal of Core Component C is to provide ongoing information management and statistical support for lymphoma research. This includes support for the specific projects described in the Lymphoma Program Project Grant and for lymphoma research which utilizes the database. The major responsibilities of Core C with regard to information management include data entry, assurance of quality control, provision of routine queries or reports to program investigators, maintenance of the overall hardware and software environment, customizing data management for specific investigations and planning for growth and evolution to more sophisticated approaches as needed. Core Component C also provides statistical support for the investigators in the Program for study design and analyses. Staff of the core include personnel with statistics, information management and data management experience.